The Hektoen Institute of Medical Research Site Consortium - Adolescent Medicine Trials Network for HIV/AIDS Interventions (ATN) Operations and Collaborations Center (UM2 Clinical Trial Optional)

ABSTRACT Cook County Health
Despite advances in Human Immunodeficiency Virus (HIV) diagnostics, care, and prevention strategies,
infection rates continue to rise across the United States, particularly the medically underserved of low socio-
economic status, sexual and gender minority groups, and/or racial/ethnic minority constituency, and/or
substance abusing youth. There is an urgent need to reduce the number of new HIV infections among at-risk
youth and improvements in numbers across the HIV care continuum. The Adolescent and Young Adult
Research (AYAR) at Core Consortium will participate in the Adolescent Medicine Trials Network for HIV/AIDS
Interventions (ATN) as it has since 2001. The AYAR consortium will continue to work collaboratively within the
ATN structure to assist in the development and implementation of interventional studies that address the ATN
scientific priority areas across the HIV/AIDS prevention and treatment continuum among adolescents and
young adults (ages 13-24) through primary, secondary, and tertiary prevention approaches. The consortium's
HIV experienced, multidisciplinary clinical and community-based staff will be responsible for ATN subject
recruitment, retention, and safety in our well-established adolescent HIV care program and consortium
network, with the use of innovative methods, to reach the most underserved and highest risk communities of
the Chicagoland area. They will continue to improve upon its leadership model with meaningful and
sustainable community engagement efforts, targeting high HIV prevalence areas, leveraging local health
departments and community partners in promoting and engaging youth in health care and research directed at
ending the HIV epidemic. The consortium will maintain and establish new Community Based Organization
(CBO) partnerships and conduct community outreach activities in targeted areas within Cook County's high
HIV-affected areas and with a focus on sexual minority groups. AYAR will continue to support CBOs via in-
person or virtual meetings and events, educational sessions, and sexually transmitted infection (STI) testing.
AYAR will continue to maintain an active research Youth Advisory Board (YAB) with regular meetings via in
person or virtual means. The consortium will increase sexual health education and awareness of HIV
prevention strategies and assist with linkage to care for pre-exposure prophylaxis (PrEP) and HIV care. The
AYAR will provide site, laboratory, pharmacy, and community capacities, to support impactful research studies
identified by the ATN Executive Committee and Scientific Leadership Group, in collaboration with the
Operations and Collaborations Center (OCC). Our investigative team has decades of experience with
recruitment, prevention, and care of at-risk youth and large-scale longitudinal cohort studies. This study will
capitalize upon productive existing partnerships to articulate the drivers of the ongoing HIV epidemic among
the most vulnerable populations in the Chicagoland area in order to identify the most effective, expeditious,
and scalable strategies to address this ongoing public health crisis.